SCH: Novel Multi-View Statistical Machine Learning for Alzheimer's Disease

Alzheimer’s disease (AD) is the most common type of dementia without curative medications. Early
detection of AD is thus essential for timely intervention and effective treatment development. Multi-view
data provides a transformative approach to enhance the understanding, diagnosis, and prediction of AD.
This research aims to develop three novel statistical machine learning methods for AD research using
multi-view imaging, genomic, and clinical data, focusing on multi-view brain and genomic network analysis,
significant differential feature testing, and diagnosis and survival analysis. The specific aims of this
proposal include: 1. Develop a novel high-dimensional multi-view data decomposition based on
uncorrelated common and distinctive latent factors (C&DLFs) to construct multi-view networks, with
application to comparing brain and genomic networks across AD statuses; 2. Develop an optimal false
discovery rate (FDR) control method based on a novel semi-parametric hidden Markov random field for
high-dimensional spatial multiple testing, with application to identifying significant brain and genomic
differences across AD statuses; 3. Develop a highly accurate deep-learning-based diagnosis and survival
framework for high-dimensional tabular data, incorporating feature selection and view ablation to enhance
cost-effectiveness and data accessibility in clinical practice; 4. Apply the three proposed methods to four
large-scale AD-related datasets and disseminate the methods with an open, efficient software package.
The three novel methods in our project will undergo rigorous theoretical and numerical analyses. The
research team’s extensive expertise in multi-view data analysis, network analysis, imaging genetics, high-
dimensional statistics, deep learning, and AD research will make significant contributions to the project’s
success.
RELEVANCE (See instructions):
The research goal is to develop three novel statistical machine learning methods for Alzheimer’s disease
(AD) using multi-view imaging, genomic, and clinical data. These methods will focus on multi-view brain
and genomic network analysis, significant differential feature testing, and diagnosis and survival analysis.
The proposed project will enhance our understanding of neuro-genetic associations in AD and significantly
contribute to biomarker discovery, early detection, and improved patient survival in AD.